Mobile Health Intervention to Increase HIV Self Testing and Linkage to Services for High-Risk Men in China

PROJECT SUMMARY
The overarching goal of this R01 application (PA-18-278: Innovations in HIV Testing, Adherence, and
Retention to Optimize HIV Care Continuum Outcomes) is to advance the science of mobile health approaches
to increase uptake of repeat HIV self-testing (HST) and linkage to HIV-related care with populations that
underperform on these steps of the HIV care continuum. We propose an intervention entitled “WeTest-
WeLink” that builds on years of formative work with MSM in China (R34MH106349), demonstrating promising
effects from a pilot RCT and strong indication of intervention acceptability, feasibility, and cultural sensitivity.
The intervention uses the “WeChat” mobile app platform, which offers multiple features built into the app that
facilitate health information delivery and communication channels (e.g., capacity for private texts, group chats,
video sharing, GPS, instant messaging, real-time audio and visual communication). Guided by the Information-
Motivation-Behavioral (IMB) model and Minority Stress Theory, we will employ a user-centered design process
to refine and expand app features to support repeat HST uptake, behavioral risk reduction, stigma coping
strategies, and self-efficacy to link to HIV care. We will use an Effectiveness-Implementation Hybrid Type 1
design consisting of a three site, 2-arm RCT to test HST and linkage to HIV related care outcomes as well as
qualitative research to examine implementation and scalability. We will recruit 1,800 HIV negative MSM in
three cities with HIV high-prevalence among MSM – Chengdu (9%), Suzhou (13%), Wuhan (11%) – allocated
to the intervention (access to the WeTest-WeLink app) or control group (education about HST and passive
referral to HIV care for individuals who test HIV positive). We will assess participants at 6-, 12-, and 18 months
to measure intervention effects on primary outcomes: repeated use of HST (including photographic
confirmation) and linkage to care for individuals who test HIV-positive. Secondary outcomes include sexual risk
behaviors and use of HIV prevention services, and we will conduct mediation analysis to examine theoretical
mechanisms of behavior change. We will qualitatively assess intervention-related process characteristics that
enable and/or impede implementation and scalability informed by the Consolidated Framework for
Implementation Research (CFIR). This project will provide the first known evidence for a mobile health
approach to optimize both HIV testing and linkage to care as part of a single intervention continuum with MSM.
Such findings can be crucial for optimizing the care cascade in populations that underutilize HIV services, such
as MSM in China and elsewhere in the world where HIV testing and linkage to care services are sub-optimal.

Public health relevance
PROJECT NARRATIVE This project has the potential to improve the science and implementation of app-based mobile health approaches to optimize both HIV testing and linkage to care as part of a single intervention continuum with MSM. The proposed research can provide evidence of the impact of this intervention approach on repeated HIV self-testing and linkage to care, and can hasten the translation of this approach to resource-limited areas in the US and elsewhere in the developing world where HIV testing and linkage to care services are sub- optimal.